The role of the dz217 mutation in somatosensory dendrite morphogenesis

PI: Buelow, Hannes E.
Project Summary of parent grant R01NS129992
Behavior in multicellular organisms is controlled by neural circuits in which neurons integrate
synaptic input and compute output. Most neurons are bipolar and comprise dendrites and axons,
which mediate reception and transmission of information, respectively. Dendrite branching is
necessary for correct circuit assembly. We are using the pair of PVD and FLP neurons in the small
nematode C. elegans to investigate basic genetic and molecular mechanisms of dendrite
development. Both PVD and FLP neurons elaborate highly branched, non-overlapping dendritic
arbors that employ conserved mechanisms during dendrite morphogenesis. Previously, we have
focused our studies on genes that are required for the formation of the dendritic arbors of PVD and
FLP neurons, with a focus on non-autonomously acting factors. In this proposal, we will focus on two
aspects that have been previously understudied, both with regard to PVD development, but also in
general with regard to dendrite patterning. In genetic screens we have identified several loci that
restrict branching. In Specific Aim 1, we will study loci we identified in genetic modifier screens of a
hypomorphic allele of the KPC-1/Furin proprotein convertase. We had previously found that KPC-
1/Furin functions cell-autonomously in PVD neurons to negatively regulate dendritic branching. This
aim is designed to elucidate the molecular mechanisms by which KPC-1/Furin restricts branching. In
addition, we will study an allele that constitutes a mutation in a transcription factor binding site of a
gene encoding an actin regulatory protein. In Specific Aim 2, we will focus on a putative rab-related
GTPase, which we have found to function in the epidermis to restrict dendrite branching. This aim is
focused on determining the mechanisms by which this putative GTPase controls branching non-
autonomously from the skin. In addition, we will study an allele that displays the same phenotype as a
mutant in the GTPase to gain additional insight into the process of how branching is restricted.
Finally, The FLP and PVD neurons provide a unique opportunity to study the processes of heterotypic
tiling (i.e. the tiling of receptive fields between two different types of neurons) and the control of
dendritic field size in molecular detail. In a combination of forward and candidate genetic screens we
have identified a number of genes that regulate tiling between FLP and PVD dendrites. Therefore, in
Specific Aim 3, we will determine the genetic and molecular mechanisms that govern heterotypic tiling
and the control of field size. In summary, this proposal is aimed at understanding the molecular and
genetic mechanisms that restrict and control dendritic branching on the one hand and, the processes
that ensure establishment of non-overlapping dendritic fields of defined size between different types
of neurons.

Public health relevance
PI: Buelow, Hannes E. Project Relevance of parent grant R01NS129992 Nerve cells receive their input by way of elaborately branched structures termed dendrites, which are defective in numerous neuropathological conditions such as certain forms of mental retardation or autism spectrum disorders. While significant progress has been made in regard to many aspects of neural development, much remains to be learned about basic aspects of dendrite development. Here we propose to investigate novel mechanisms of dendrite development using a combination of C. elegans molecular, genetic, imaging and biochemical approaches.